Utilization and Health Outcomes for Veterans with Expanded Health Care Accessâ¯

Background: Improving access to high-quality care is a top priority for VHA. However, access is difficult to
measure, especially in the ever-changing U.S. health care landscape. VHA currently focuses on perceived
satisfaction measured from survey questions, or wait times measured with administrative data. The wait time
metric has received considerable focus in both the Choice and MISSION Acts, yet experts recognize that wait
times are imperfect; they are not only challenging to interpret, but they are rarely available from community
providers, hindering any VHA to non-VA comparisons. VHA leaders tasked with implementing the Choice and
MISSION Acts desire better evidence-based access measures so they can evaluate their program’s impact.
Our inability to measure access threatens the future of VHA as a health care provider. Without new metrics
that track gaps or improvements in access, VHA is likely to invest in the wrong initiatives, fueling critics who will
argue that privatization will fix the programs Significance/Impact: Our objective is to develop new measures
of access. These new measures will provide causal information on gaps in VHA services, while also showing
the potential impact that expanded access would have on Veterans’ health. Our study leverages natural
experiments in the form of arbitrary administrative rules that enable Veterans to access care outside VHA in
the forms of Medicare and VA Community Care (VACC). Veterans close to the rule thresholds are similar, yet
some gain access based on the rule, while the others do not. We can leverage this information to understand
how this added access changes health care utilization and health outcomes. Our results will be useful to
national and local VHA leaders as they grapple with how to best improve access with a limited budget.
Innovation: It is not feasible to perform a large-scale randomized clinical trial to find the effect of access on
utilization and health outcomes. Correlational studies will miss important confounders, and as everyone knows
correlation does not equal causation, which is what VHA leaders need most. Instead, we apply novel
econometric techniques to take advantage of natural experiments and find the causal effects of increasing
access. The results from this approach can then be used as a measure of access for both VHA and non-VA
care. This is directly aligned with HSR&D's priorities on access to care, research related to the MISSION Act,
and advancing health services research methods across conditions or care settings. Specific Aims: Aim 1:
Find the causal impact of Medicare eligibility on Veteran utilization and health, and identify procedures and
diagnosis groups that are most affected. Aim 2: Find the causal impact of VACC on Veteran utilization and
health, and find the procedures and diagnoses most affected. Aim 3: Identify subgroup analyses that would
give crucial information to VHA leaders. Methodology: In Aims 1 and 2, we will apply an econometric
technique called regression discontinuity design. We will gather a near complete census of VHA and non-VA
records for all recent Veteran VHA users, allowing for precise claims-based measures of utilization, health, and
mortality. In Aim 1, this approach leverages the sharp change in Medicare eligibility that occurs at age 65 to
find the effect of Medicare on utilization and health. Aim 2 uses the same approach, but instead of age 65, we
use the driving distance rules to find the effect of VA Community Care on utilization and health. For these aims
we will examine both overall effects and procedure and diagnosis specific effects. In Aim 3, we take a
combined approach of working with operational partners and applying machine learning techniques for
heterogenous treatment effects to identify and examine metrics and measures that can be used for policy
formation. Next Steps and Implementation: By working with operational partners through Aim 3, we will
identify opportunities and barriers to implementing measures and metrics derived from our results. This
information will be key to setting policy related to VHA’s evolution into a provider and payer of Veteran care
while ensuring that Veterans receive high-quality care in both VHA and non-VA settings.

Public health relevance
Improving access to high-quality care is a top priority for VHA, and the Veterans Choice Program (VCP) and MISSION Act are intended to increase Veteran access to care. However, access is difficult to measure, and correlational studies are prone to unobserved confounders. Our study leverages natural experiments, in the form of arbitrary administrative rules, that enable Veterans to access care outside VHA in the forms of Medicare and VA Community Care (VACC). We apply novel econometric techniques to identify a new measure of access and find the causal effects of increasing access on Veteran health care utilization and outcomes. Using linked VA and non-VA care data from CY 2007-2017, our results will show gaps in VHA services as well as the causal effect of expanded access for Veterans. The findings from this research will provide crucial information that VA must have to effectively implement the MISSION Act and provide high-quality care to Veterans.